Function and regulation of two key serine proteases in insect immunity

Project Summary
Extracellular serine proteases and their non-catalytic homologs coordinate key defense mechanisms
in insects. This includes responses of mosquitoes against pathogens and parasites that cause
serious human diseases. Proteolytic cleavage generates active phenoloxidases (POs), thioester
proteins (TEPs), Spätzle and other cytokines. PO catalyzes the production of reactive chemicals to
sequester and kill the invading organisms. TEPs opsonize parasites, targeting them for destruction.
Spätzle and other cytokines trigger intracellular signaling pathways to induce the expression of
antimicrobial peptides and other defense proteins. In insect vectors of human diseases, the protease
networks may be evaded or disrupted by proteins from the intruders. Knowledge of the system
components and their interactions from biochemical model insects such as Manduca sexta is useful
for gaining detailed molecular understanding of fundamental aspects of insect innate immunity,
including these protease cascades and provides basic knowledge that can guide studies of similar
systems in insect disease vectors. We have elucidated a part of the M. sexta protease network that
activates proPO in response to bacteria and fungi. In this network, recognition proteins bind to
microbes and activate the proteases in a cascade mode. We have annotated 193 genes encoding
serine proteases and their homologs, identified 36 of the proteins in larval hemolymph, and acquired
data indicating that some of them play critical roles in immune signal transduction. Based on the
molecular probes, purified proteins and working experience, we propose to investigate two critical
steps of the protease network, which are conserved in dipteran species, by combining hemolymph
fractionation, recombinant protein production and processing, sequence and expression information,
and state-of-the-art mass spectrometry. The specific aims of this project are to: 1) characterize the
system initiation by examining interactions of peptidoglycans, two recognition proteins, and
hemolymph protease-14 precursor (proHP14) at the domain level; 2) identify 1−2 proHP6-activating
proteases and elucidate their activation mechanisms. New knowledge gained in this project will
improve understanding of insect immunity at a biochemical level and stimulate related research in
vector species.

Public health relevance
Public Health Relevance This research will further elucidate the constitution, function and regulation of an extracellular network of extracellular serine proteases and their homologs in a model insect, which mediates immune responses by producing active phenoloxidases, cytokines and antimicrobial peptides to kill pathogens that cause serious human diseases such as malaria. The acquired knowledge will be useful for understanding similar systems and disrupting parasite transmission in vector species.